The New Zimmerman Program for the Genetics and Biology of von Willebrand Factor and von Willebrand Disease

PROJECT SUMMARY: OVERALL
This Program Project Grant (PPG) aims to address important gaps in knowledge concerning the genetic,
molecular and biologic control of von Willebrand factor (VWF) and pathogenesis of von Willebrand disease
(VWD). The PPG consists of 4 projects and 3 cores that all focus on VWF and mechanisms influencing its genetic
regulation, expression, dysfunction, increased clearance, interactions with FVIII and the role of carbohydrate
modification in VWF biology. While this is a new PPG application, this program has access to tens of thousands
of samples and extensive biodata from the pre-existing PPG, the Zimmerman Program. Project 1 will focus on
resolving, by identifying common and rare variants, including complex loci, the condition called low von
Willebrand factor; the 20-25% increase in VWF levels seen in individuals from African Ancestry; and the increase
in VWF levels observed with aging. Cohorts of subjects with low VWF, with no sequence variants in VWF will
undergo whole genome and long read sequencing. Whole genome sequencing of multiple multiethnic cohorts
will allow for admixture studies that will leverage the power of trans-ethnic fine mapping and haplotype
association. In active collaboration with Project 1, Project 2 will assemble and analyze one of the largest
collections of phenotypic, genomic, and multi-tissue transcriptomic, proteomic and other -omics data to identify
molecular signatures of low-VWF/VWD that will lead to novel insights into pathways associated with disease
etiology. Project 2 will analyze human multi-omic data in large and well-characterized cohorts and shed additional
light on the pathological events that lead to low-VWF/VWD and to age-dependent changes in VWF. With these
discoveries, we will generate polygenic risk scores for low VWF and VWD. Project 3 will investigate distinct
features of how and where VWF and FVIII are expressed; whether an intracellular chaperone effect of VWF can
reduce the cellular stress associated with FVIII expression, and will characterize the influence of VWF on the
clearance and subsequent immunogenic nature of FVIII. Project 4 will focus on the role of glycans in VWF
biology and will investigate the roles that N and O glycans play in VWF biosynthesis characterize glycans
involvement in VWF activation and define the impact of glycans in regulating VWF clearance pathways. Core
A is the administrative core that will facilitate communication between the centers involved in this multi
institutional PPG, and will provide all administrative oversight. Core B is the Bioinformatics Core and the site for
all genome and mass spec -omics studies involved in this PPG. In addition, Core B will operate the Zimmerman
Analytical Platform, our secure web-based interface, developed to oversee the exchange of MultiOmics data,
patient samples and biodata on the Velos Database in Core C. Core C is the PPG Biorepository and Central
Laboratory that will oversee the distribution of approximately 95,000 samples from 7,000 individuals to the
different projects and will coordinate the recruitment of 7 Primary Clinical Centers that will be following our
enrolled subjects. Together these studies will comprehensively study novel aspects of VWF biology and
pathobiology, and will shed new light on the pathogenesis of VWD.

Public health relevance
PROJECT NARRATIVE: OVERALL This new program project is focused on the genetics and biology of von Willebrand factor (VWF) and von Willebrand disease (VWD). With a sophisticated MultiOmics approach, the program will address the genetics and genomics of low VWF, the determinants of higher VWF in individuals of African Ancestry, the effects of aging in VWF levels and bleeding symptoms, and determine the molecular causes of VWD that lie outside of the coding sequence for VWF. By studying the life cycle of VWF and its intimate relationship with Factor VIII, with a combination of cellular and animal models, the program will also address the molecular mechanisms that determine VWF expression in different endothelial cell beds, its role on protection of Factor VIII from the unfolded protein response and the impact of glycosylation on expression and trafficking. Finally we will also study the impact of VWF glycobiology on clearance pathways and inflammation, and the immunomodulatory role of VWF. These proposed synergistic and complementary studies will shed light on the pathophysiology of the most common inherited bleeding disorder.